Glucocorticoid Receptor Dysregulation: a Genetic Risk Factor for Excessive Alcohol Consumption in High Drinking in the Dark (HDID-1) Mice

Project Summary Binge drinking has significant negative consequences for health and society, and is a major predictor for the development of an alcohol use disorder (AUD). The High Drinking in the Dark (HDID-1) line of mice, selectively bred for high blood ethanol concentrations (BECs) in a limited access binge-like drinking task, exhibit differential gene expression of a number of glucocorticoid receptor (GR) regulator proteins relative to their low- drinking founder line, HS/Npt. GR expression has been shown to be altered in response to chronic alcohol exposure and to promote further alcohol intake in dependence-like models, but GR dysregulation has not yet been identified as a genetic risk factor for excessive alcohol consumption in non-dependent animals. Preliminary data show that HDID-1 mice exhibit a dose-dependent reduction in binge drinking when given mifepristone, a GR antagonist, after only being exposed to a single 2-hour ethanol drinking session. These data suggest that selection for high BECs in the HDID-1 line has led to a sensitized GR system that may promote binge drinking. The goal of this fellowship project is to investigate the role of enhanced GR activity as a genetic risk factor for excessive alcohol consumption. Aim 1 will characterize GR expression and transcriptional activity in the brains of the high-drinking HDID-1 mice relative to the low-drinking founder line, HS/Npt. Specifically, GR and GR-related signaling genes in the nucleus accumbens (NAc) will be quantified, as GR expression in the NAc has previously been shown to promote alcohol intake. Aim 2 will determine whether pharmacological manipulation of GR in the NAc can bi-directionally modulate binge drinking. Bilateral cannulation will be performed in the NAc of (1) HDID-1 mice to deliver a GR antagonist and attempt to reduce binge drinking, and of (2) HS/Npt mice to deliver a GR agonist and attempt to increase binge drinking. The results of this aim will determine whether GR manipulation in the NAc is sufficient to alter binge drinking. Aim 3 will investigate whether GR antagonism in HDID-1 mice is sufficient to prevent escalated drinking after chronic intermittent ethanol (CIE) vapor exposure, a model of relapse-like drinking. The results of this aim will determine whether the same mechanisms driving binge drinking in HDID-1 mice also underlie relapse-like drinking. Aim 1 utilizes a basic science approach to examine molecular pathways that may have been altered through selection pressure, while Aims 2 and 3 will provide translational insight into potential pharmacological treatments for patients with AUD. Together, the experiments in this project will provide a better understanding of how GR activity in the brain contributes to excessive alcohol consumption in both non-dependent and dependent-like models of drinking.

Public health relevance
Project Narrative Genetics significantly contribute to the risk for the development of an alcohol use disorder (AUD). The goal of this project is to identify the role of dysregulation of a part of the stress system, the glucocorticoid receptor, as a genetic risk factor for excessive alcohol consumption in both non-dependent and dependent models of drinking using genetically at-risk High Drinking in the Dark (HDID-1) mice. The results of this project will determine whether the same genetic mechanisms driving binge drinking also underlie relapse-like drinking and may identify biological targets for the prevention and treatment of AUD.